Life-long phenotypic correction of CF airways

Title: Life-Long Phenotypic Correction of CF Airways
Project Summary/Abstract:
Cystic fibrosis (CF) is caused by mutations in the cystic fibrosis conductance regulator (CFTR) gene.
Knowledge of CFTR function and cell type expression has advanced greatly since its discovery in 1989, with
notable discoveries in the last 5 years. While significant advances have been made with small molecule
modulator therapies to restore function for most CFTR mutation classes, ~10% of people with CF have not
benefited from these strategies. We have a demonstrated track record of using many categories of viral and
non-viral based reagents for gene delivery to the airways. Our goal is to achieve life-long correction from a
single dose of aerosolized viral vector. As such, efficient delivery of a therapeutic gene or gene editing
machinery to airway progenitor cells is critical. In this proposal, we advance two gene therapy technologies and
compare their pros and cons. Both strategies take advantage of the impressive transduction efficiency and
large packaging capacity of Adenoviral (Ad)-based vectors. Two potential drawbacks of Ad vectors are
transient expression and immune response, both of which will be addressed. In Aim 1 we engineer Ad-based
viral vectors with improved progenitor cell targeting and correction. We compare chimeric vectors based on
Ad5 with fibers from species B adenoviruses. In addition, we show that Ad has the capacity to penetrate airway
mucus barriers but investigate mucolytics that may further improve vector delivery. In Aim 2 we contrast
efficiency of CFTR functional correction using gene delivery and gene editing in vitro. To achieve gene
correction, will use an adenine base editor (ABE) delivered with Ad (Ad-Cas9-ABE) to correct CFTR in cells.
As a proof of principle, we focus on the CFTR nonsense mutation R553X. This mutation results in premature
termination codon and does not respond to any small molecule modulator. Following vector delivery, we will
confirm gene editing using a combination of next generation sequencing and Cl- current measurements. The
achieved levels of phenotypic correction will be compared to the PB/Ad-CFTR gene addition strategy. We
hypothesize that regardless of gene therapy strategy, a maximum threshold level of Cl- current is achievable.
This current is similar in heterozygous (CFTR+/-) or wild-type (CFTR+/+) cells. In Aim 3 we contrast gene
delivery and gene editing efficiency in pig airways. We will generate a CFTRG551D/R553X compound heterozygous
pig model to screen leading vectors designed to correct a CF mutation for which no current small molecule
treatments are available. Our goal is to provide a life-long gene repair strategy that could be adapted for a
great number of CF causing mutations. This proposed research is highly innovative. The reagents, methods,
and data generated by these experiments could be applied to gene addition or base editing for other
monogenic disorders, thereby significantly advancing the gene therapy field.

Public health relevance
Project Narrative: The proposed research is relevant to public health because genetic and acquired diseases affecting the airways pose major disease and economic burdens. This proposal takes an innovative approach using novel gene addition and base editing gene therapy strategies to correct cells lining the airways of a large animal model of cystic fibrosis. In this proposal, our goal is to create reagents with the ability to efficiently, safely, and persistently correct cystic fibrosis causing gene mutations in appropriate cell types.